Evaluation of risk-based supplemental ultrasound and MRI screening strategies for women with dense breasts

PROJECT SUMMARY
Approximately 43% of women undergoing breast cancer screening have mammographically dense breast
tissue that absorbs x-rays and makes cancers difficult to visualize. A new FDA rule effective September 2024
requires radiology facilities to inform women with dense breasts that they should consider other imaging tests,
in addition to a screening mammogram, to help find cancers earlier. However, no consensus guidelines
regarding supplemental screening for women with dense breasts exist. Ultrasound and MRI are clinically
available screening modalities, but policymakers cite inadequate evidence regarding their effectiveness and
studies to date suggest that supplemental ultrasound or MRI screening of all women with dense breasts have
poor benefit-to-harm profiles. We propose a new conceptual framework tailoring supplemental screening of
women with dense breasts based on a women’s risk of being diagnosed with an advanced cancer despite
regular mammography screening, which offers the potential to realize the benefits of early detection while
limiting the number of women experiencing harms due to false-positive results. This competitive renewal
extends our current project to evaluate both supplemental ultrasound and MRI screening, evaluate outcomes
by screening round and advanced cancer risk, compare the effectiveness of supplemental screening to
mammography alone in an emulated randomized trial, and use simulation modeling to evaluate lifetime
outcomes of population-level screening strategies targeting supplemental screening based on advanced
cancer risk. Our comprehensive study leverages data on over 1.5 million screening exams in the Breast
Cancer Surveillance Consortium, a large alliance of breast imaging registries including 64 healthcare facilities
performing supplemental ultrasound or MRI screening. Using data from breast cancer screening of women with
dense breasts in routine clinical practice, we will (Aim 1) characterize supplemental ultrasound and MRI
screening performance by screening round and by advanced breast cancer risk; (Aim 2) use an emulated trial
causal inference framework to estimate the effectiveness of supplemental screening versus mammography
alone, overall and according to advanced cancer risk; and (Aim 3) use the validated University of Wisconsin
CISNET breast cancer simulation model to estimate lifetime benefits and harms associated with population-
level risk-based supplemental screening strategies (Aim 3). Our results will identify women with dense breasts
for whom the benefit-to-harm tradeoffs for supplemental screening are favorable. In the coming year, more
than 27 million U.S. women will receive letters informing them that they have dense breasts and should
discuss screening options with their providers, without any established consensus recommendations to guide
them. Our findings will provide the rigorous and generalizable evidence that is needed by women, healthcare
providers, and policymakers considering breast cancer screening options for women with dense breasts.

Public health relevance
PROJECT NARRATIVE Breast cancer screening with mammography does not perform well for many women who have dense breast tissue, but there are not clear guidelines regarding additional screening options for these women. Our study will provide evidence regarding the effectiveness of supplemental ultrasound and MRI screening in clinical practice and estimate the long-term benefits, harms, and costs of screening strategies in which supplemental screening is targeted to women with dense breasts based on their advanced breast cancer risk after routine mammography.